Effect of Acetylcholinesterase inhibitors on Bone Metabolism and Fracture Risk Factors among older adults with mild to moderate Alzheimer's Disease

Project Abstract
Older adults with Alzheimer's disease and related dementias (ADRD) have a 2-fold increased risk of clinical
bone fracture, and 33% higher rate of morbidity and mortality following fracture. Our prior study showed clinical
fractures were reduced by 18% among those prescribed an acetylcholinesterase inhibitor (AchEI). With both
cognitive and non-cognitive benefits, AchEIs such as donepezil would be valuable in a fracture prevention
program, for older adults with ADRD, with multiple complementary and synergistic components. However, the
pathways by which AchEIs reduce fracture risk represent a significant gap in knowledge. Before incorporating
AchEIs into a multicomponent program, the specific effects of AchEIs on bone metabolism must be understood.
The objective of this application is to measure the effect of ADRD treatment with AchEIs on fracture risk factors
including bone mineral density (BMD), bone turnover markers, and bone quality. Our central hypothesis is that
AchEIs reduce fracture risk through direct effects on bone metabolism via stimulation of osteoblastic bone
formation and reduction in osteoclastic bone resorption. We will recruit adults aged >50 years from the Memory
Disorders Clinic with mild to moderate ADRD (N = 45) who will be randomized 2:1 to either the AchEI donepezil
10 mg daily or placebo, respectively. From this biomarker-diagnosed cohort of older adults with mild to moderate
ADRD, we will address the following Specific Aims: 1) Determine change over 12-months in Bone Mineral
Density measured by dual x-ray absorptiometry associated with the initiation of donepezil; 2) Determine change
over 6- and 12-months in Bone Turnover measured by (A) the Bone Resorption Marker C-telopeptide (CTX) and
(B) the Bone Formation Marker Procollagen 1 intact N-terminal Pro-peptide (P1NP) associated with the initiation
of donepezil; 3) Determine change over 12-months in Bone Quality measured by Trabecular Bone Score
associated with the initiation of donepezil. In addressing this significant area, the current application focuses
on several NIA priorities including multiple comorbidities and care for adults with ADRD. The proposed study is
innovative in its comprehensive, prospective assessment of bone metabolism among adults with biomarker-
based diagnosis of ADRD initiating AchE.

Public health relevance
Project Narrative Because older adults with Alzheimer's disease and related dementias (ADRD) have a 2-fold increased risk of clinical bone fracture, the project is relevant to public health by measuring the effect of acetylcholinesterase inhibitors on bone metabolism (bone density, bone turnover, and bone quality) among older adults with ADRD. In line with several NIA priorities including multiple comorbidities and care for adults with ADRD, the study will focus on fracture risk factors among older adults with ADRD.